Research 3- Morton

Project Summary
This project addresses fundamental mechanisms that may contribute to the acute symptoms of concussion and
related mild traumatic brain injuries. Our long-term goal is to increase understanding of mechanisms underlying
acute neurological dysfunction, so that diagnosis and/or treatment can be substantially improved. This work is
expected to be significant for the large number of individuals who suffer from concussions, including the
substantial number who do not recover fully after single or repetitive hits. The project focuses on the
phenomenon of Spreading Depolarization (SD), which has emerged relatively recently as a key contributor to
lesion progression in patients in the ICU with severe traumatic brain injury or stroke. There is very limited
knowledge about whether SDs occur in other neurological conditions. In 2018 we presented the first evidence
that SDs occur in a murine concussion model, and another group provided a first publication with indirect
measurements of SD in a similar model. The challenge now is to provide additional direct electrophysiological
recordings of SD, combined with simulatenous measures of behavior, to determine whether concussion-induced
SDs are responsible for the well-known acute symptoms of concussion. If SDs are necessary and sufficient to
explain the symptoms, then interventions targeting SD could be very valuable for these patients, and the
discovery could suggest new opportunities for early diagnosis. Furthermore, the large disruptions in neuronal
and vascular function caused by SD could contribute to a window of vulnerability to second hits – a possibility
that has not previously been investigated. This project therefore addresses key gaps in knowledge about
mechanisms linking SD to concussion symptoms and vulnerability. We will use a mouse concussion model and
combinations of electrophysiological and behavioral recordings, together with high-throughput anatomical
analyses to assess for signs of neuronal injury. Specific Aim 1 tests whether the short term depression of
synaptic activity that follows SD underlies post-concussion behaviors. Specific Aim 2 tests whether the massive
disruptions in blood flow and/or synaptic activity that follow SD render the brain more vulnerable to a second hit
during this acute phase. Successful completion of these aims is expected to identify SD as a significant
contributor to the symptoms and consequences of concussion, and open new doors to detection and treatment
of this very common and often severely debilitating type of brain injury. The project is very well suited to the
interdisciplinary environment of the COBRE Center. Extensive input from both preclinical and clinical mentors
and colleagues, and excellent core facilities will provide an outstanding platform for multiple high-impact
publications and progression to independent extramural funding success.

Public health relevance
Project Narrative These studies aim to help improve the diagnosis and treatment of concussions and other mild traumatic brain injuries. There is currently limited understanding of the brain changes that occur immediately following a concussion, and what interventions may limit initial symptoms. We will examine whether waves of brain activation termed “spreading depolarization” are triggered during concussions, and whether these events underlie the acute symptoms of a concussion and susceptibility to a second hit.